Craniofacial Morphogenesis and Tissue Regeneration Gordon Research Conference and Seminar

Project Summary
The craniofacial complex exhibits enormous diversity across vertebrate species and is also one of the most
affected in human congenital anomalies. This high degree of variation in evolution and disease is reflected by
the complexity of craniofacial development. Formation of the head and face involves interactions between cell
types from all major germ layers. Subsequently, the structures that emerge serve to support the brain and
sensory organs, features underlying the successful radiation of vertebrates. In recent years, innovations in
genetics, genomics, and imaging have rapidly advanced our mechanistic understanding of craniofacial
development. These insights into craniofacial development have in turn informed our understanding of how
development is altered in evolution and disease, and how developmental principles can be applied to therapeutic
interventions in craniofacial repair. The scientific program will focus on how emerging technologies (e.g., single-
cell approaches and human stem cell technology) are synergizing with classical embryological and genetic
approaches to advance our understanding of craniofacial development, disease, and regeneration. A keynote
session will explore the earliest stages of human craniofacial development, the study of which is being made
possible by new single-cell approaches and human stem cell technology. We will discuss how these emerging
technologies are being applied to animal models of major craniofacial anomalies, expanding our ability to study
craniofacial development in diverse non-model organisms, and leading to new approaches to correct and repair
craniofacial differences. The conference will encourage a range of scientific and technological approaches while
fostering an inclusive forum for colleagues from a wide range of backgrounds. A goal of the conference is to
bring together leaders in the field and early-stage investigators, including those who are new to the craniofacial
field and those from underrepresented groups. In addition to enjoying presentations of cutting-edge, unpublished
research, a goal is to form collaborations between researchers with complementary yet distinct expertise that
will advance craniofacial research in the years ahead.

Public health relevance
Project Narrative The 2024 Gordon Conference on Craniofacial Morphogenesis and Tissue Regeneration will bring together diverse leaders with an interest in human congenital anomalies affecting the head and face. The goal of the conference is to share how research in development, evolution, and regeneration of the vertebrate head can be leveraged toward new approaches to the diagnosis, prevention, and repair of human craniofacial disorders.